Computational Neuroscience to Decode Higher-Order Fear in PTSD

PROJECT SUMMARY/ABSTRACT
The objective of this K23 is to support new mentored training in the computational neuroscience of higher-order
threat learning and memory in posttraumatic stress disorder (PTSD) as the candidate transitions to an
independent career as research faculty specializing in integrating lab work with real-world experience sampling
in larger, heterogenous research samples to further translational efforts in conceptualizing and treating trauma
and anxiety psychopathology. PTSD affects ~6% of the US population annually and is associated with substantial
health and economic burden. RDoC-aligned threat conditioning paradigms have substantially contributed to
etiological models of PTSD and exposure therapies, yet some patients fail to respond to treatment or experience
relapse. One potential explanation is that exposure primarily addresses directly associated stimuli and
experiences. Consequently, reductions in fear tend not to spread to more nebulous and indirect higher order
networks of generalized threat associations commonly seen in pathological anxiety. Prolific nonhuman animal
work has produced a neurobiological model of the mechanisms of higher-order threat learning, yet systematic
translation to humans is almost nonexistent. Thus, we lack a compelling human neural model needed to anchor
translational efforts that integrate higher-order learning principles into the theoretical framework of exposure.
During this award, the candidate will build on initial functional MRI training and incorporate new training
in advanced computational decoding applications of multivariate pattern analysis (MVPA) to test the complex
interplay of aversive learning and memory mechanisms that result in dense and difficult-to-treat higher-order
threat associations. Aim 1 will a) apply MVPA to test how memory integration mechanisms facilitate threat
generalization across higher-order pathways in implicated medial temporal structures (basolateral amygdala,
hippocampus, perirhinal cortex) and medial prefrontal cortex; b) determine the long-term durability of higher-
order threat generalization biases memory retrieval at 24-hour or 1-month after initial learning; and c) test the
hypothesis that higher-order threat generalization is heightened in PTSD compared with participants without
psychopathology. Aim 2 will extend this work and address heterogeneity inherent to the PTSD diagnosis via
subgroup and dimensional anxiety-related trait modeling. Aim 3 uses these lab-based neural metrics of threat
generalization to predict real-world daily experience of PTSD and anxiety-related symptoms and physiology,
which is needed to bring neural models in better alignment with the clinical reality of pathological anxiety. To
facilitate this work, the candidate will receive extensive supervised training in longitudinal ambulatory
assessment designs employing state-of-the-art wearable technology and experience sampling methods. The
proposed work can advance neurobiological models of anxiety-related psychopathology and set the stage for
addressing prominent treatment limitations. This award lays the groundwork for the candidate to achieve these
research and training goals and to contribute to efforts optimizing treatments using lab and real-world data.

Public health relevance
PROJECT NARRATIVE This proposal investigates neurobehavioral higher-order threat learning mechanisms using functional neuroimaging and psychophysiology to provide new working knowledge to address gaps in existing exposure therapy protocols for PTSD and anxiety-related conditions. This neurobehavioral research will use precision behavioral phenotyping in a heterogeneous sample and will integrate with a longitudinal ambulatory assessment design to validate the utility of threat learning and memory task measures for predicting real-world experiences of subjective anxiety and physiology across multiple weeks. Together, these projects aim to advance neurobehavioral knowledge on difficult-to-treat forms of threat generalization, shape future work in this area with the incorporation of real-world anxiety data into neurobiological models of pathological anxiety, and contribute to the next wave of translational efforts to improve neuroscience-informed treatments.